Data Management and Biostatistics Core

Core D: Data Management & Biostatistics Project Summary/Abstract
The Data Management and Biostatistics Core (DMBC) will serve as both a collaborator and a valuable
resource for all Projects and Cores related to this Program Project. The DMBC will consult on the design of all
Projects to assure data collected will adequately address the scientific hypotheses. The DMBC will lead in the
application of appropriate statistical and methodological techniques, and collaborate in data analysis and report
preparation for all Cores and Projects. The DMBC's role is especially crucial for analysis of associations
among longitudinal growth/decline and symptomatic conversion patterns of all disease markers across all
Projects and Cores. The significance of the Data Management and Biostatistics Core is to provide a central
and relational program-wide high quality database and assure analytic integrity of all publications from the
ACS. It is the mission of the DMBC to enhance and support the research objectives of the ACS by providing
timely and reliable data management and appropriate analytic expertise across the Program Project.